MEDSCAN: Mobile Enabled Diagnostics for Schistosomiasis Control Analytics

PROJECT SUMMARY
Schistosomiasis is endemic in 54 countries and infects nearly 240 million people worldwide per year. Sub-
Saharan Africa endures a disproportionate burden, accounting for over 90% of infections. In Kenya, the site of
our study, 17 million out of the nation’s 50 million citizens are at risk for schistosomiasis infection. Of the at-risk
population, school-aged children represent the primary risk group, and the many morbidities of infection are
amplified over a child’s lifespan.
After decades of mass drug administration, it is clear that more aggressive and targeted interventions are
necessary to move towards the elimination of schistosomiasis. Unfortunately, this recognition has not yet
resulted in the development of the tools that public health officials need to make this transition. To address this
unmet need, we propose the development of the MEDSCAN (mobile enabled diagnostics for schistosomiasis
control analytics) platform to improve schistosomiasis surveillance efforts. This software package builds off of
the successful history that we have had in the development of image-processing algorithms for diagnostic
purposes. MEDSCAN will consist of a mobile application that can analyze point-of-care diagnostic tests and a
web-based administrator dashboard for viewing real-time operational performance metrics and other advanced
analytics.
We have assembled an interdisciplinary consortium that consists of mobile health software and global
health expertise at Vanderbilt University, a world-leader in schistosomiasis diagnostics from Leiden University
Medical Center, and a successful history of neglected tropical disease program management and field
research at the Kenya Medical Research Institute. To meet our shared goals, our specific aims will: 1) evaluate
the cellular network in Western Kenya in preparation for mobile health research, and develop the mobile and
web platforms; 2) perform a usability analysis on the platform and make iterative refinements; 3) complete a
thorough laboratory evaluation of the MEDSCAN application and a single-site pilot systems check; 4) use the
MEDSCAN platform in a 10-month, observational surveillance study.
By transforming the already widely utilized point-of-care test into a “connected” diagnostic, MEDSCAN can
serve as the gateway to high-resolution surveillance that is necessary to shift efforts from control to elimination.

Public health relevance
PROJECT NARRATIVE Schistosomiasis is endemic in 54 countries and 700 million people are at risk of infection. School-aged children are the most at-risk population, and infection is associated with long term morbidities. As disease control efforts transition to elimination, there is a pressing need for improved surveillance tools.